Dissecting inflammatory outcomes following eCigarette exposure

Project Abstract
Elucidating molecular pathways that coordinate inflammatory responses and histopathology is of paramount importance
in the study of lung disease and possible treatments. Our current R15 led to novel discoveries related to roles for RAGE
in coordinating cellular responses to tobacco smoke exposure. The use of electronic cigarettes (eCigs) is a phenomenon
that has emerged in the United States during the last few decades. Flavored eCig vaping is steadily rising and troubling
trends for eCig use suggest an astonishing 1 out of 10 adolescents vape regularly. eCigs involves exposure to aerosols
that are generated when heating diverse flavorings, propylene glycol and glycerine. The resulting aerosols are believed to
be less toxic, notwithstanding the accumulation of harmful molecules including acrolein and formaldehyde. Our
preliminary studies revealed RAGE-mediated responses to eCig exposure and foreshadow the need for renewed research
of this receptor. SAGEs are semi-synthetic glycosaminoglycan ethers that are potent modulators of inflammation in
numerous animal models of human disease, and are in preclinical development for periodontitis, oral mucositis, and
bladder inflammation. Importantly, SAGEs significantly inhibit interactions between RAGE and its many ligands
necessary for signaling. The present proposal is the first to thoroughly assess the biology of RAGE signaling in the
context of eCig exposure. A key innovation of this proposal is a collection of animal models that tightly control
RAGE expression including RAGE knock out mice, tissue-specific transgenic mice that up-regulate RAGE, and
mice harboring phosphorylation deficient RAGE alleles. The central hypothesis is that exposure to eCig aerosols
adversely impacts pulmonary health, culminating in significant inflammation and parenchymal cell death. We also
hypothesize that abrogation of RAGE with SAGEs diminishes the myriad inflammatory events in the exposed lung. Two
specific aims are proposed, and each uses advanced molecular methodologies employed by undergraduate students
to test these hypotheses. The studies outlined in this proposal will validate RAGE signaling as a target pathway for
the prevention or attenuation of lung diseases in individuals unable or unwilling to remove eCig exposure but may
also help to clarify RAGE-mediated pathogenesis in a number of physiological processes.

Public health relevance
Project Narrative At the core of medical biology research is the goal to discover targetable pathways that cause debilitating disease progression. The vaping of eCigs has become more popular since their introduction a few decades ago due to widespread belief that they are less harmful; however, their true long-term health impact is still underexplored. The goal of this project is to characterize RAGE-mediated inflammatory effects of eCig exposure and demonstrate RAGE targeting as a potential means of ameliorating disease progression in the compromised lung.